Structure-Property-Function Relationship in mRNA/CARTs for Targeted mRNA Delivery

Project Summary/Abstract
The proposed research will improve the understanding of structure-property-function
relationships in formulations of charge-altering releasable transporter (CART) gene delivery vectors.
These materials demonstrate remarkable efficiency for mRNA transfection with low cytotoxicity due
to charge-neutralizing degradative chemistry and have shown remarkable selectivity towards
different organs in vivo depending on the chemical structure of the CART. A predictive understanding
of how chemical variation affects nanostructure and biological activity will be established. If
successful, a set of design rules for CARTs will guide the optimization of mRNA/CART complexes
for improved cellular transfection and catered cellular/organ selectivity enabling the development of
site-specific CART / RNA therapeutics.
The fellow will be the first to perform detailed structural and dynamic studies using advanced
cryogenic transmission electron microscopy (cryoEM) and in situ X-ray scattering, illuminating the
morphological properties of mRNA/CART nanoparticles. Additionally, this proposal will establish if
nanostructure variation arises from changes in formulation technique and CART chemical structures
(cation, lipid) and relate these nano-structural variation to differences in biological function. The
fellow will develop microfluidic mixing protocols (t-mixer) and screen mRNA/CARTs with differing
sizes/morphologies in vitro with cell cultures to establish correlations between functional outcome
and nanostructure. In addition to cryoEM and scattering, supplementary measurements of zeta
potential, size, phase, thermal transitions, supramolecular interactions, etc. will be carried out to
determine the effect physico-chemical properties has on nanostructure in different CART
formulations. In separate future research not covered by this proposal, the most distinct
mRNA/CARTs will be further studied with in vivo experimentation in mouse models with our
collaborators. The fellow will also receive formal and informal training in the responsible conduct of
research, teaching, career development skills applicable to their future career goals of becoming a
research professor and participate in outreach and mentoring. These studies will take place in a
highly interdisciplinary training environment at Stanford University in the lab of Prof. Robert
Waymouth, in close collaboration with Dr. Christopher Tassone at SSRL (SLAC national laboratory).

Public health relevance
Project Narrative The recently developed charge-altering releasable transporter (CART) gene delivery vectors exhibit remarkable efficiency for mRNA transfection and expression with site specific selectivity and low cytotoxicity. We propose to study the structure-property-function relationship of mRNA/CARTs complexes with advanced microscopy and scattering techniques to elucidate how physicochemical properties affect nanostructure. Distinct formulations will be further screened to relate biological function to structure allowing for the establishment of a set of design rules to aid the development of CARTs for efficient and selective immunotherapies.